The Objective Identification of Bruising in Children using Diffuse Reflectance Spectroscopy

PROJECT SUMMARY
The objective of this study is to examine the validity of reflectance spectroscopy as a diagnostic tool for
objectively diagnosing bruising in infants and children. In cases of suspected child physical abuse, bruising is a
key clinical finding. The identification of bruising is extremely important, as it 1) triggers standard of care child
physical abuse medical evaluations in infants and young children; and 2) often forms the “reasonable
suspicion” basis for making reports to child protective services.
Yet, the current clinical assessment of bruising in children is subjective and imprecise. One difficulty is that
bruising can be difficult to detect in children with darker skin tones, as melanin is a chromophore that can
obscure or distort characteristic color appearance of extravasated blood in the skin. Unfortunately, this clinical
imprecision has contributed to racial disproportionality of child physical abuse evaluations and reporting. The
current gold-standard of clinical bruising confirmation is time-dependent, i.e., serial evaluations of the lesion
that demonstrate color changes and disappearance of the lesion in a matter of weeks. In the suspected child
physical abuse scenario, the time-dependent confirmation of bruising is problematic, as decisions on whether
to undertake medical evaluations and/or make reports to child protective services require immediate, point-of-
care determinations.
We propose that reflectance spectroscopy is an ideal candidate for this pediatric point-of-care tool because
it is painless, non-invasive, quickly utilized, and potentially scalable for widespread use in smartphone
cameras. The use of reflectance spectroscopy in other lines of clinical research—melanoma, neonatal
hyperbilirubinemia, and forensic dating of bruising--provide the scientific substrate for our novel and innovative
application of this technology. We propose that, irrespective of skin tone, reflectance spectroscopy will
demonstrate a reflectance pattern that is characteristic of traumatic bruising and is different from common
bruising mimics (i.e, birthmarks, vascular malformations, etc). Finally, we aim to utilize the patterns of
hemoglobin breakdown products to create a predictive model that identifies a bruise with high sensitivity and
specificity.
We will utilize a multi-center approach to diversify our patient population and ensure sufficient patient
volumes, recruiting 260 children (ages 0-17 years) who have suspected bruising and common bruising mimics.
Using a laboratory-grade spectrometer, we will obtain spectral readings of both affected and adjacent
unaffected skin areas on all patients, controlling for skin tone. Spectral analysis will be performed using a least-
squares fitting method and Monte Carlo simulations will be used to help generate a predictive model. We
believe that, ultimately, the point-of-care use of reflectance spectroscopy will diminish unnecessary healthcare
utilization and racial disparities in child physical abuse evaluations and reporting.

Public health relevance
PROJECT NARRATIVE Bruising in young children is a frequent indicator of physical abuse and can have significant medical, legal and social consequences if identified. It is vital that we have an objective means of identifying bruises in children, as doing so can impact proper healthcare utilization, diminish unnecessary child welfare investigations, and minimize racial disparities in medical, social (i.e., child welfare) and legal invesigations.